NHERF1 regulates MRGPRX2/MrgprB2 responses in mast cells

PROJECT SUMMARY
Mast cells are tissue resident innate immune cells that have been best characterized for their role in mediating
allergic diseases. A new development in mast cell research has been the identification and characterization of a
novel G-protein coupled receptor, Mas-Related G-Protein-coupled Receptor X2 (MRGPRX2). This receptor
promotes pseudoallergic reaction to U.S. Food and Drug Administration (FDA)-approved drugs and chronic
inflammation in diseases such as asthma, rosacea and hives (urticaria). While the role of MRGPRX2 in promoting
allergic reactions has been thoroughly investigated, the molecular mechanisms utilized by this receptor is poorly
understood. Our data suggests that Na+/H+ exchanger regulatory factor (NHERF)1, an adaptor protein, regulates
MRGPRX2- and MrgprB2- (the mouse ortholog of the human receptor) induced responses in mast cells.
Specifically, reducing the expression of NHERF1 in mast cells results in decreased intracellular Ca2+ mobilization
and degranulation via MRGPRX2/MrgprB2 in vitro. Consistent with this data, NHERF1 also promoted
anaphylaxis in MrgprB2-dependent mouse models of paw edema and passive systemic anaphylaxis in vivo. This
proposal builds up on these observations; the central hypothesis is that NHERF1 is a critical regulator of
MRGPRX2 responses in mast cells. Using a novel mouse strain that we have recently generated, Cpa3-
Cre+:NHERF1fl/fl, primary human CD34+ stem cell-derived mast cells and humanized mice, we will determine the
role of mast cell-specific expression of NHERF1 in regulating mouse MrgprB2 and human MRGPRX2 receptors
in vitro and in vivo (Aim 1). In Aim 2, we will explore the mechanisms through which NHERF1 modulates mast
cell response. Specifically, we will determine whether phosphorylation of NHERF1 is important for NHERF1
regulation of MRGPRX2/MrgprB2. We will identify the components of the NHERF1-interactome and signaling
proteins and pathways through which NHERF1 functions in mast cells by using transcriptomic and proteomic
approaches. Additionally, we will delineate the role of NHERF1-microRNA (miR)155-suppressor of cytokine
signaling (SOCS1)-Src homology 2 (SH2) domain containing inositol polyphosphate 5-phosphatase 1 (SHIP-1)
axis in promoting mast cell activation. Given the critical role of mast cell-MRGPRX2 in causing pseudoallergic
reactions and chronic inflammation in allergic diseases, elucidation of the mechanisms by which NHERF1
contributes to MRGPRX2-mediated allergic response is of significant scientific and clinical importance. We firmly
believe that successful completion of the proposed studies will likely lead to the identification of potential targets
of the MRGPRX2 pathway that can provide insights into the future development of drugs for not only
pseudoallergic reactions but also other mast cell-mediated inflammatory diseases.

Public health relevance
PROJECT NARRATIVE A G-protein coupled receptor on mast cells, MRGPRX2 plays an important role in causing pseudoallergic reactions to several U.S. Food and Drug Administration (FDA)-approved drugs as well as mediates chronic inflammation in diseases such asthma, rosacea and hives (urticaria). In this proposal, we will examine the role of an adaptor protein NHERF1 in regulating MRGPRX2-induced mast cell responses. These studies will augment our understanding of the mast cell biology and also provide insights for the development of novel therapeutics for allergic and inflammatory reactions.